Interdisciplinary Research Training in Cancer Biology

Our interdisciplinary program will focus on training pre-doctoral students and post-doctoral fellows in cancer biology so they can effectively decipher important research questions associated with human cancer. This will be accomplished by integrating established, successful programs in various cancer biology themes together with clinical exposure into one cohesive program. Trainees will receive didactic and non-didactic instruction; laboratory-based basic science research training in cancer research and cutting-edge clinical applications; and career development as independent cancer biologists. To further growth as important members of the scientific community, students and fellows will receive ample training to articulate their ideas and communicate them effectively, evaluate biomedical research and mentor others in scientific excellence. This program assembles a cohesive group of faculty from various departments at the University of Kentucky (UK) College of Medicine, College of Arts and Sciences, and College of Pharmacy. In the past 10 years, our program faculty trained 104 doctoral students and 109 post-doctoral students; our faculty have the experience and interdisciplinary focus to guide this group of trainees to function in research teams pursuing multidisciplinary investigations. We mentor trainees to be proficient at utilizing hypothesis-driven approaches as well as discovery-oriented research design to address key problems. All trainees are required to complete foundation courses in graduate-level Genetics, Biochemistry, Immunology, Pharmacology, Physiology, Cell Biology, Molecular Biology, Ethics, Biostatistics, and Bioinformatics, as well as Biology and Therapy of Cancer, which emphasizes clinical aspects of human cancer. Unique features of this program include interdisciplinary training emphasizing bench to bedside (and vice versa) research topics, as well as a mandatory Clinical Perspectives in Oncology workshop that encompasses tumor boards and clinician shadowing to provide a bridge between the fundamental biology of cancer and clinical cancer. Training also involves mandatory participation in the weekly Markey Cancer Center (MCC) Seminars, Cancer Biology journal club, training workshops in specialized topics, and the Fellowship Boot Camp to increase the number of individual fellowships and grants from our trainees. The ultimate objective of this program is to develop a cadre of future scientists who will lead integrative team approaches and understand the complex issue of cancer as it relates to potential prevention and treatment strategies. To ensure our commitment to the clinical translation of basic science discoveries, MCC Associate Director Kathleen O’Connor, PhD, and Director B. Mark Evers, MD, will serve as PIs for this team-based training program. Accordingly, with the enthusiastic support of the MCC and the UK Vice President for Research, this training program will mentor the next generation of cancer researchers to better understand and treat cancers.

Public health relevance
PROJECT NARRATIVE This multidisciplinary training program represents a team approach, involving multiple principal investigators who will continue to mentor predoctoral students and post-doctoral fellows. The program will emphasize fundamental aspects of cancer biology, translational science of cancer and therapeutics, and clinical cancer, as well as prepare trainees as independent scientists and investigators who can become fully integrated in multidisciplinary cancer care teams.